Understanding the cellular time machine that enables rejuvenation

PROJECT SUMMARY
Nearly every human malaise is enhanced by age. Given the rise of the aging population, there is the urgent need
for treatments that improve organ function and block or reverse aging. Such rejuvenation of organisms, tissues,
and cells has recently become possible through approaches such as parabiosis and in vivo cellular
reprogramming. For instance, the transcription factors OCT4, SOX2, KLF4, and cMYC (OSKM) can reprogram
somatic cells to induced pluripotent stem cells (iPSCs) and reset the epigenetic profile, one of the most
dependable hallmarks of aging, of the starting somatic cell to a new embryonic state. In an exciting modification
of the original iPSC reprogramming method, partial OSKM-mediated reprogramming approaches were recently
developed that rejuvenate tissues in vivo. In the initial proof-of-concept investigation, the cyclic induction of
OSKM in aged mice yielded notable outcomes including enhanced expansion of pancreatic cells, improved
glucose tolerance, and accelerated muscle regeneration after injury. Subsequently, OSKM-induced partial
reprogramming was successfully implemented in a cell type-specific manner in vivo. Furthermore, recent
advancements in vitro have demonstrated that partial reprogramming of ‘old’ fibroblasts by OSKM induced a
rejuvenated reprogramming intermediate, wherein somatic identity is preserved. This rejuvenation was
quantified to be the equivalent of approximately 30 years, as determined by epigenetic clock measurements.
Thus, faithfully reprogramming cells undergo progressive and continuous rejuvenation of the epigenome, long
before the pluripotent state is achieved. Intriguingly, the rejuvenated reprogramming intermediates can revert to
the fibroblast state upon withdrawal of reprogramming factor expression and maintain its youthful state.
Additionally, crucial functional attributes such as collagen production and migration reverted to a more youthful
state, indicating comprehensive cellular rejuvenation. Partial reprogramming by OSKM may therefore have broad
implications in regenerative medicine. However, the feasibility of partial reprogramming by OSKM in clinical
settings is limited due to concerns regarding its potential to induce cells with a tumorigenic potential. We
hypothesize that the mechanistic understanding of how partial reprogramming by OSKM induces epigenetic
rejuvenation will lead to the discovery of strategies that can be more safely applied in vivo to induce rejuvenation.
To unravel the molecular mechanisms underlying rejuvenation by partial OSKM reprogramming, we will 1) map
the changes in the transcriptome, chromatin landscape, transcription factor binding, and epigenetic age across
the OSKM-induced partial reprogramming, and based on these data, 2) identify the gene-regulatory and
chromatin networks of rejuvenation and regulators of age. We expect that these approaches will begin to define
rejuvenation factors that can be applied to other models and provide critical insights into the determinants of
epigenetic aging.

Public health relevance
PROJECT NARRATIVE Nearly every human malaise is enhanced by age. Given the rise of the aging population, there is the urgent need for treatments that improve organ function and block or reverse aging. Towards that goal, this project will investigate at a molecular level a strategy for cellular rejuvenation based on partial reprogramming.